Regulated assembly and function of macromolecular complexes in genome maintenance

Project Summary
The overarching goal of our research is to understand the regulatory mechanisms that ensure
accurate transmission of the genome during cell division. Macromolecular machines including the
DNA replisomes and kinetochores execute chromosome replication and segregation,
respectively; and they scaffold many post-translational modification enzymes to control their
assembly and function. Mutations of these enzymes cause errors in chromosome replication and
segregation, leading to gross chromosomal rearrangements and aneuploidy, respectively. In the
next five years, we will investigate two areas, focusing on how post-translational modification
enzymes regulate the assembly and function of DNA replication complexes and kinetochores. In
the first area, we will study how cells prevent incomplete DNA replication, which is a major cause
of gross chromosomal rearrangements. Specifically, we will investigate how cells regulate the
loading of the Mini-Chromosome Maintenance (MCM) complex to ensure a timely completion of
DNA replication, and how cells remove excess MCM at the end of DNA replication, both are
required to prevent incomplete DNA replication. In the second area, we will study how cells
promote kinetochore assembly in the M phase via protein phosphorylation and control kinetochore
disassembly after chromosome segregation through protein sumoylation and ubiquitination
pathways. Using a quantitative proteomics technology and an array of genetic, biochemical and
cell biological assays, we will dissect the signals that control reversible kinetochore assembly to
accommodate centromere replication and chromosome segregation. Together, these studies will
illuminate the still enigmatic regulatory processes that are disrupted in the genome instability
mutants and in diseases.

Public health relevance
Project Narrative Problems in DNA replication and chromosome segregation give rise to chromosomal rearrangements and aneuploidy, which are a hallmark of cancer and many other diseases. This project will investigate the regulatory mechanisms that ensure accurate DNA replication and chromosome segregation through the cellular control of macromolecular machines that execute these processes.